INHALED CORTICOSTEROIDS /ADRENAL FUNCTION IN COPD PATIENTS

The role of inhaled corticosteroids in altering the course of chronic obstructive pulmonary disease (COPD) is not well understood. The Lung Health Study is a multicenter, clinical trial that is testing the hypothesis that inhaled triamcinolone,12 micrograms daily, will prevent the deterioration of pulmonary function in pateints with mild to moderate COPD. In order to assess the potential for inhaled steroids to cause adrenal suppression, Cortrosyn stimulation tests are performed on individuals at baseline, one year, and three years after entry into the trial. The primary outcome measure will be the response at 30 and 60 minutes of serum corticol. The comparision groups will be those treated with triamcinolone compared to those treated with a similar-appearing inhaled placebo. A total of 1017 patients are being studied at 10 centers throughout North America, with a total of approximately 400 participating in this substudy. The other participating institutions include: University of California at Los Angeles, University of Oregon Health Sciences Center, Mayo Clinic, University of Alabama at Birmingham, Henry Ford Hospital, Western Reserve University, University of Manitoba, University of Pittsburg, University of Minnesota (Coordinating Center), and Johns Hopkins University.